SPECIALIZED ANALYTIC DATA SUPPORT for SEER-MHOS DATA EXPANSIONS

The purpose of this solicitation is to obtain specialized analytic data support to demonstrate the utility of recent
SEER-MHOS data expansions and to investigate new methodological approaches taking advantage of the MHOS
repeated multi-cohort design.